HTORR Cold Storage Temperature Monitoring Modernization

Project Summary:
The Human Tissue and Organ Research Resource (HTORR) is a division of the National Disease
Research Interchange (NDRI), a not-for-profit NIH-funded organization whose mission is to
provide the biomedical research community with human tissues for research. The importance of
human tissues for use in research is continually growing and evolving as new tools and
technologies are developed, requiring the resources supporting this research to evolve as well.
The primary objective of our R24 Equipment Program grant submission to the active PAR-24-028
“Modern Equipment for Shared-use Biomedical Research Facilities: Advancing Research-
Related Operations” proposal is to modernize our cold storage mapping and temperature
monitoring infrastructure and capabilities for the biorepository to ensure that the resources
available to the research community can continue to meet the ever-changing needs. Importantly,
this modernization will allow for improved control, consistency, and documentation of sample
management, which is an important step in facilitating research rigor and reproducibility
throughout the research communities that we serve.

Public health relevance
Project Narrative The importance of human biospecimens in research continues to grow, and the Human Tissue and Organs for Research Resource (HTORR) program provides innovative services to support investigators that require human tissues and organs for their research. Over the past 4 years, over 500 scientific papers were published by investigators that received biospecimens from HTORR, demonstrating HTORR's indispensable contribution to the research community and the impact of these services on the search for new treatments and cures for common and rare diseases. Importantly, as new tools and technologies are developed, the resources supporting this work also need to evolve and modernize to be able to continue providing the best quality resources to facilitate rigor and reproducibility throughout the research communities that we serve.